Biomarkers to Stratify Risk of Progression from Latent TB Infection to Active

The currently available tuberculin skin test (TST) and interferon gamma release assays (IGRA) cannot distinguish between infected persons who i) contain the infection and eliminate the organism (

Public health relevance
Many people exposed to the bacteria that cause Tuberculosis (TB) become infected but only a small number will progress to disease. This proposal will develop new tests that can identify people who are either at high risk or low risk of developing TB. The knowledge gained will allow targeting TB treatment to the right group of infected people and preventing them from developing Tb and spreading the bacteria to others.